Evaluating a Multilevel Intervention to Increase Colonoscopic Follow-up after Abnormal Stool-based Colorectal Cancer Screening in a Community Safety-Net Setting

Project Summary/Abstract
Colorectal cancer (CRC) is the second most common cause of cancer-related mortality in the United
States (U.S.). Although several effective prevention and early detection screening methods are available,
screening remains underutilized. The most feasible CRC screening modality for average-risk individuals in low
resource settings, such as Federally Qualified Health Centers (FQHCs), is the stool-based fecal
immunochemical test (FIT). One challenge of using FIT, however, is that follow-up colonoscopy is required
after an abnormal (i.e., positive) result to check the colon and rectum for polyps or cancer. The benefit of FIT
screening on CRC risk and mortality is realized only if timely colonoscopy is achieved. FQHCs are an
integral component of the safety-net health system and represent a strong infrastructure for health service
delivery research. Prior research suggests that only 18-57% of FQHC patients with abnormal stool-based
screening results receive colonoscopy. There is limited research that focuses on identifying effective strategies
to improve follow-up after an abnormal FIT result. In addition, much of the prior research has been conducted
in integrated healthcare settings, although most care for underserved populations is delivered through a
patchwork of public and private primary care providers, specialty providers and hospital settings. Therefore, it
is paramount to understand how to increase follow-up of abnormal FIT results in these complex and real-world
settings, which can yield findings with more relevance for the most vulnerable patient subgroups.
In the proposed application, we will utilize a pragmatic, cluster randomized trial design within one of the
largest FQHCs in the nation to test the effectiveness of a multilevel and multicomponent intervention
(patient, provider, health system) that targets several barriers to follow-up in both the FQHC (primary care) and
GI specialty care settings. The intervention is informed by prior research and is innovative in that it addresses
barriers to follow-up colonoscopy in non-integrated primary care settings and within GI specialty care settings
and strengthens care coordination between FQHCs and GI providers. The study will be conducted in 6 clinics
within the same FQHC system. Three sites will be randomized to usual care and three to the intervention
condition. The specific aims are to: 1) compare the effectiveness of the multilevel intervention to the usual care
condition on receipt of a colonoscopy within 6 months of an abnormal FIT result (primary outcome); 2)
systematically assess the quality of and challenges to intervention implementation to understand the feasibility
and relative importance of intervention elements; and 3) measure the cost of intervention implementation to
inform potential for dissemination and spread. The proposed study addresses important gaps in CRC
prevention and control research by focusing on completion of the CRC screening process in a medically
underserved population. Findings have the potential to change clinical practice and can be adapted for other
FQHCs and clinical settings that face similar challenges in managing patients with abnormal FIT results.

Public health relevance
Public Health Relevance Colorectal cancer (CRC) is common and deadly, but screening has been demonstrated to reduce incidence and mortality. Federally Qualified Health Centers (FQHCs) are government-funded primary care facilities that frequently use stool-based CRC screening tests that are effective yet require colonoscopy follow-up when results are abnormal. The proposed study will evaluate the impact of a multilevel, multicomponent intervention on follow-up colonoscopy rates after abnormal screening test results in a large FQHC with low colonoscopy follow-up rates.